Diversity Center for Genome Research at Meharry

Project Summary
Meharry Medical College is committed to bridging the gaps for underrepresented, disadvantaged minority
(URM) groups by establishing a Diversity Center for Genome Research (DCGR). The Diversity Center will narrow
inequitable representation gaps for URM by realizing our vision to promote African ancestry genomic research
through infrastructure building and the formation of basic, clinical, and computational science research teams
that are inclusive, interdisciplinary, and community-engaged. Also, the proposed DCGR will facilitate a
sustainable partnership among HBCU including MMC, Fisk University, and Tennessee State University in
Nashville. The establishment of DCGR will complement MMC’s ongoing genomics capacity-building initiatives.
Meharry DCGR research theme will focus on studying the genetic basis of chronic diseases prevalent in AA.
Project 1 (Borza) will study the loss-of-function variant genome-phenome association in inflammatory diseases,
such as dementia, cancer, tuberculosis, and sarcoidosis (also termed: Besnier-Boeck-Schauman) that typically
presents in lungs (skin or lymph nodes) as abnormal collections of inflammatory cells. Project 2 (Ivanova) aims
to correlate the genetics of inflammatory/mitochondrial responses to immunophenotypes to identify prognostic
indicators of health disparities. Project 3 (Singh) aims to address barriers to recruitment and build a blood
repository of AA people to evaluate disease biomarkers associated with health disparities. The DCGR efforts will
be spearheaded by three Cores. The Administrative Core will manage the Center's administrative, fiscal, and
scientific aspects, including accreditation of new graduate programs, oversight of career enhancement activities
for students, trainees, and faculty, and fostering synergy with other ongoing genomic training and career
development activities. The Genomic Workforce Development Core will initiate new academic activities,
including new graduate programs in genomics and genetic counseling training to educate and train minority
students and researchers in genomic sciences for diversifying the URM genomics research workforce. The
Community Engagement Core will enhance sustainable partnerships with community-based organizations and
the AA community to address their concerns and promote their participation in the Center’s research activities.
The Cores will finalize, implement, and oversee a management plan that stimulates, coordinates, integrates, and
monitors activities and functions across all elements of the Cores addressing: Aim 1. Transform the
organizational infrastructure and processes supporting academic excellence in African ancestry genome
research at MMC; Aim 2. Promote scholarship within the research collaborations and mentorship networks to
enrich the quality of genome research and provide a nexus for scientific community building among basic, clinical,
and computational science stakeholders with social and academic integration; Aim 3. Maximize the effectiveness
of a faculty cohort to advance genome research competencies and attainment of career milestones by fostering
faculty development and making MMC a magnet that attracts other URM genomics scholars.

Public health relevance
Project Narrative To bridge gaps in the genomics workforce for the underrepresented, disadvantaged minority groups, Meharry Medical College is seeking to establish a Diversity Center for Genome Research. The Center will realize our vision to promote African ancestry genomic research through infrastructure building and the formation of basic, clinical, and computational science research teams that are inclusive, interdisciplinary, and community-engaged. It will also facilitate a sustainable partnership among HBCU including MMC, Fisk University, and Tennessee State University in Nashville to train the genomics workforce.